The Role of Blood-Brain Barrier Disruption on Ischemic Brain Injury and Cognitive Impairment in Sickle Cell Disease

PROJECT SUMMARY/ABSTRACT
Despite advances in sickle cell disease (SCD) treatment, patients continue to experience stroke, endure
lifelong cognitive disability, and have a reduced life expectancy of 43 years. While previous imaging studies have
focused on anemia and hypoxia as risk factors for stroke, they have not adequately explored other potential
disease mechanisms in SCD, such as systemic thromboinflammation and blood-brain barrier (BBB) disruption,
which may contribute to increased stroke risk. Although thromboinflammation-targeted approaches have shown
promise in mitigating BBB disruption and reducing brain injury in animal models of SCD, their effectiveness in
humans remains unexplored. To bridge this gap, this K23 proposes a prospective cohort study to investigate the
central hypothesis that BBB dysfunction, associated with specific thromboinflammatory pathways, predicts silent
infarct progression and cognitive decline in patients with SCD. The study has three main aims. In Aim 1, using
both a well-validated MR sequence and a novel MR sequence, it will assess BBB permeability in patients with
SCD compared to healthy controls, stratified in relation to existing infarct burden. In Aim 2, the study will
investigate specific thromboinflammatory pathways associated with BBB dysfunction by examining unique gene
expressions associated with elevated BBB permeability. Finally, in Aim 3, during a 30-month follow-up period,
the study will determine whether baseline BBB permeability can predict the progression of ischemic brain injury
and cognitive decline (executive function).
This K23 proposal will be implemented with the support of an interdisciplinary team comprising the PI, as
well as, mentors and consultants who are experts in relevant fields including: SCD, cerebral small vessel disease,
advanced MRI methods, platelets and thromboinflammatory disorders, cognitive function in SCD, and
biostatistics. The candidate, an adult cerebrovascular neurologist, has a long term goal to become an
independent physician-scientist and to integrate advanced neuroimaging with blood-based markers of
thromboinflammation to best achieve a comprehensive understanding of cerebral microvasculopathy and its
cognitive consequences. The career development plan outlines three key areas: (1) expertise in advanced
neuroimaging acquisition, data processing, and application; (2) foundation in systemic thromboinflammation; and
(3) foundation in cognitive testing to translate MRI findings into clinically relevant outcomes. Successful
completion of the proposed research and career development activities will fill knowledge gaps for the developing
PI and provide compelling evidence on the role of BBB integrity and thromboinflammation in ischemic injury and
cognitive decline in SCD. Furthermore, it will guide the development of an independent R01 proposal aimed at
investigating BBB integrity as a novel neuroprotective strategy for treatment of cerebral small vessel diseases.

Public health relevance
Project narrative Sickle cell disease, affecting 1 in 365 Black infants, commonly leads to stroke, ischemic brain injury, and cognitive disability, hindering academic milestones and employment. This K23 proposal investigates the early pathomechanisms of stroke, such as thromboinflammation and breakdown of the blood brain barrier, to identify novel therapeutic targets. To achieve this, adults with sickle cell disease and healthy controls will undergo sequential brain MRI, blood testing, and longitudinal cognitive assessment over 30 months.